Federated and transfer learning methods for cross-ancestry and cross-phenotype integration of genomic datasets

Abstract
This proposal aims to develop advanced data integration methods for improving genetic risk prediction
in under-represented non-European populations. Genome-Wide Association Studies (GWAS) have yielded
important biological insights into the heritable basis of many complex traits and diseases, and polygenic risk
scores (PRS) have shown promising potentials for disease risk stratification. However, since the vast majority of
participants in large-scale genomic datasets are from European ancestry (EA) populations, the performance of
current PRS is much poorer in non-EA populations than in EA populations, which may exacerbate existing health
disparities. Despite some recent inclusive data collection efforts, current risk prediction methods cannot effectively
address the heavily unbalanced sample sizes across populations. Robust data integration methods are needed to
leverage similarities in genetic architectures across ancestral populations, phenotypic correlations and pleiotropy,
and variant functional annotations while accounting for different sources of heterogeneity. Moreover, as various
national and institutional biobanks become available, efficient information-sharing strategies with data privacy
considerations are needed for combining data across biobanks to improve sample diversity and sample size. This
proposal will address these needs by developing a methodological framework with advanced transfer learning (TL)
and federated learning (FL) techniques for integrating various sources of data to bridge the gap of risk prediction
across populations. Specifically, in Aim 1, we will develop a TL method to integrate ancestrally diverse data
based on high-dimensional models with a distance-based regularization to characterize the similarities across
populations, and a communication-efficient FL algorithm that jointly fits the TL model across multiple biobanks with
only summary-level statistics. In Aim 2, we will develop methods that enable joint analyses of multiple phenotypes
in association tests and risk prediction models. We will develop an FL algorithm to combine data from multiple
biobanks for cross-phenotype association test, and a TL method with an angle-based regularization to leverage
genetic correlations among mixed types of phenotypes in risk prediction. In Aim 3, we will develop knowledge-
graph-based TL methods that leverage the shared latent spaces between phenotype-genotype knowledge graphs
constructed from different ancestral populations and enable the incorporation of functional annotations. In Aim 4,
we will develop open-access statistical software capable of implementing the proposed methods in both offline
and cloud computing environments, and apply the proposed methods to the analysis of major depressive disorder
and cardiovascular diseases using data from the All of Us program, eMERGE, and the UK biobank.

Public health relevance
Narrative This project aims to develop advanced methods and computational tools to address biases and disparities caused by the lack of representation of non-European populations in large-scale genomic datasets and biobanks. We will develop transfer learning methods to improve polygenic risk prediction in under-represented populations by leveraging similarities in genetic architectures across diverse populations and related phenotypes, as well as communication-efﬁcient and privacy-preserving federated algorithms that integrate larger bodies of data across biobanks and large-scale genomic datasets to boost the power of association tests and risk prediction models. We will apply the proposed methods to study major depressive disorder and cardiovascular diseases using multiple national and institutional biobanks.